Targeting of RNA-binding protein FXR1 in HNSCC

Abstract
Head and neck squamous cell carcinoma (HNSCC) is the 6th most common cancer worldwide and accounts for
more than 90% of head and neck cancers, with a 5-year survival rate of approximately 50%. Despite specific
effective and novel therapies, most patients remain unresponsive to current treatment modalities and develop
drug resistance. Therefore, identifying new molecules that target cancer pathways, alone or in combination, is
critical for developing novel cancer therapies. In HNSCC, dysregulated RNA-binding proteins (RBPs) controls
co- and post-transcriptional events. Approaches targeting RBPs are not well established to regulate the gene
expression in cancers. Thus, new therapeutic strategies to control gene expression and tumor growth are
necessary. Our published findings demonstrate that FXR1 directly binds the RNA G-quadruplex (G4) regions of
mRNA CDKN1A and a non-coding RNA TERC (Telomerase RNA component) and promotes the growth and
proliferation of HNSCC cells. Herein, our preliminary findings indicate that methylated arginine amino acids at
the NES (nuclear export signal) and RGG (arginine-glycine rich) domain of FXR1 are responsible for G4-RNA
binding and the growth of cancer cells. However, mutation of specific arginine residues in the NES/RGG domain
abolished FXR1 binding with CDKN1A and TERC and reduced the growth and proliferation of oral cancer cells.
Thus, targeting FXR1's RGG domain with specific inhibitors is considered an appealing drug target for oral
cancer treatment. We plan to use nucleic acid-based aptamers that directly bind to the arginine amino acids
present in NES/RGG domain of FXR1 and disrupt its RNA binding activities. Hence, the overall goal of this R21
proposal is to utilize structural and biochemical assays to screen and identify aptamers specific to the FXR1
NES/RGG domain to control its gene expression activities and the growth of oral cancer cells. Two specific aims
are proposed to test this model. In specific aim1, we will determine how arginine methylation impacts FXR1 RNA-
binding functions and oral tumor progression using in vitro RNA binding assays and in vivo tumor models. In
specific aim2, we will develop an aptamer that directly binds and interfere with methylated FXR1-RNA complex
and show anti-tumor activity in our preclinical animal models of HNSCC. Our present work is an innovative,
straightforward, and robust approach to target the dysregulated RBP-mediated gene expression in HNSCC. We
will use these mechanistic findings to develop novel strategies to treat aggressive HNSCC tumors.

Public health relevance
Project Narrative The lack of molecular mechanistic insights into oral squamous cell carcinoma initiation and progression has significantly hindered the development of new, directed therapy. FXR1, an RNA-binding protein that is overexpressed in oral cancers, post-transcriptionally control gene expression of tumor suppressors in oral cancer. The experiments described in this proposal will evaluate the role of arginine methylation on FXR1 in oral tumors and identify small molecule inhibitors for FXR1 that can be developed as an interventional drug that blocks oral tumor growth and proliferation.